GYRATE ATROPHY OF THE CHOROID AND RETINA

We continue our studies of the natural history and metabolic ramifications of GA as well as the effects of chronic reduction of ornithine with an arginine-restricted diet. We continue to acquire new patients at about 3/year with emphasis on younger probands. Our molecular characterization keeps pace with >50 mutant OAT alleles now identified.